Regulatory T Cells And Bronchopulmonary Dysplasia-Associated Pulmonary Hypertension

Abstract/Summary
Bronchopulmonary dysplasia (BPD) is the most common infantile chronic lung disease that lacks curative
therapies. The development of pulmonary hypertension (PH) increases BPD-associated mortality and
morbidity. Persistent lung inflammation is central to the pathogenesis of BPD-associated PH (BPD-PH), which
is characterized by alveolar and pulmonary vascular simplification and endothelial cell dysfunction. Therefore,
this proposal aims to elucidate the mechanisms regulating inflammation in the developing lungs. Regulatory T
cells (Tregs) are a subset of CD4+ T cells that regulate innate and adaptive immune responses, prevent tissue
damage, and promote the resolution of lung inflammation and injury in adult rodents. Further, Treg density is
altered in BPD infants. However, it is unclear if these cells contribute to BPD-PH pathogenesis. Our preliminary
data indicate that hyperoxia (HO) exposure decreases Tregs, and Treg depletion potentiates HO-induced
experimental BPD-PH in mice. Thus, we propose examining the mechanistic and therapeutic roles of Tregs in
BPD-PH using well-established murine models and human biosamples. Our studies also show that Treg
depletion decreases endothelial cell (EC) density in neonatal murine lungs. Healthy lung blood vessels are
necessary for normal lung development, promoting tissue repair, and mitigating BPD-PH. The interactions
between Tregs and lung ECs are unclear. Our compelling data show that Treg depletion increases
inflammation and decreases the expression of the pro-angiogenic hormone, adrenomedullin (Adm), and its
receptor, receptor activity-modifying protein 2 (Ramp2), in the murine lung ECs. We also show that Adm
overexpression decreases HO-induced experimental BPD-PH. Further, we show that human BPD lungs have
decreased EC Ramp2 expression and Tregs. Thus, we will test the central hypothesis that Tregs experimental
BPD-PH in mice by promoting lung vascular growth, survival, and function via Adm signaling. We will use a
unique combination of molecular, cellular, functional, and translational approaches to test this hypothesis. In
Aim 1, we will use transgenic neonatal mice, flow cytometry, and single-cell RNA Seq to determine how HO
and lipopolysaccharide affect Treg phenotype and function and if adoptive transfer (AT) of Tregs can mitigate
experimental BPD-PH. In Aim 2, we will use Adm transgenics and innovative nanoparticles specifically
targeting lung ECs to determine if Tregs regulate EC homeostasis and injury in the neonatal lungs via Adm
signaling. Finally, in Aim 3, we will perform a prospective cohort study and use a well-curated lung biobank to
examine the blood and lung Treg phenotype and density in human infants with and without BPD-PH and
correlate them with the disease incidence and severity. We expect our studies to provide new insights into how
inflammation and injury are regulated in the developing lungs, and provide a mechanistic rationale for targeting
Tregs and Adm pathway to develop novel biomarkers and meaningful therapies for infants with BPD-PH.

Public health relevance
PROJECT NARRATIVE Bronchopulmonary dysplasia (BPD) associated with pulmonary hypertension (PH) or BPD-PH is a common chronic lung disease of premature infants that is associated with increased mortality, serious life-long morbidities, and lack of specific therapies. Thus, this project aims to examine the mechanistic and therapeutic roles of regulatory T cells in BPD-PH. Successful completion of our aims could lead to the development of innovative strategies to prevent and treat this debilitating disease of preterm infants.